AIM BACK UH3 Transition

ABSTRACT: Improving Veteran Access to Integrated Management of Chronic Back Pain
LBP is among the most prevalent and disabling medical problems for Veterans. Improving patient care for LBP
is a high priority for many federal agencies and recent clinical practice guidelines emphasize the importance of
non-pharmacological management of LBP. However, optimal care pathways involving non-pharmacological
treatments have not been established. Care pathways aligned with a “biopsychosocial” conceptualization of
LBP are highly valued, but are rarely delivered in routine practice environments and still need to be
investigated for their effectiveness. The overall goal of this UG3 (Planning Phase)/UH3 (Demonstration
Project) proposal is to improve access to recommended non-pharmacologic therapies for LBP in the
Department of VA Health Care System. In UG3 phase trial planning will be accomplished through two aims: 1)
establish policies, procedures, and regulatory agreements for data management and resource sharing needs
and 2) finalize research design and clinical protocols needed to conduct a high-quality, multi-center pragmatic
cluster randomized trial. The pragmatic cluster randomized trial proposed for the UH3 Demonstration Project
will compare the effectiveness of two LBP management approaches designed to enhance access to non-
pharmacological pain treatments and biopsychosocial oriented care: a) sequenced, multi-modal integrated
care pathway incorporating physical pain treatment, tailored behavioral treatment, and home base activity
versus 2) care management by pain navigator program that facilitates coordinated use of existing VA or non-
VA pain management resources. With clinical practice guidelines in mind, both pathways have been
purposefully structured to include non-pharmacological pain modulation. Veterans enrolled in the trial (n =
1,250) will be followed for primary outcomes (PROMIS Short Form scores for pain interference and function)
captured from the electronic health record and a subset (n = 630) will complete phone captured patient
reported secondary augment electronic health record capture. In Aim 1 we will examine the effectiveness of a
sequenced, multi-modal integrated care pathway for LBP, compared to a care management by pain navigator
program. Our central hypothesis is that the multi-modal, integrated care pathway will reduce pain interference
with normal activities and improve physical function compared with the care management program. In Aim 2
we will determine participant characteristics associated with greater improvements in pain interference and
function, and better adherence to each care pathway. Aim 2 will inform the potential for matching Veteran
subgroup characteristics to a specific care pathway that provides greater potential for improvement in pain and
function. This proposal is directly aligned with primary goals of the NIH-DoD-VA Pain Management
Collaboratory by aligning existing VA health system resources to expand capacity to deliver earlier non-
pharmacological pain management for the Veteran with LBP.

Public health relevance
PROJECT NARRATIVE Low back pain is a prevalent and disabling problem for Veterans that often involves pharmacological or surgical approaches that carry higher than desired risks. Non-pharmacological pain management has a lower risk profile and can be effective for pain relief, but best practices for treatment delivery to Veterans is largely unknown. This project will plan and implement a pragmatic clinical trial to examine the effectiveness of a multi- modal, integrated care pathway for low back pain, compared to a care management via pain navigator program that coordinates access to pain management services. There is high public health relevance for this proposal because it provides infrastructure to enhance pain research capacity within the Veterans Administration health care system, and directly informs on the comparative effectiveness of different pain management approaches that increase exposure to non-pharmaceutical treatments.